Blood-brain barrier and microstructural brain biomarkers of ARIA and treatment outcomes with anti-amyloid immunotherapy for Alzheimer's disease

PROJECT SUMMARY
The advent of anti-A immunotherapies is transforming the treatment of Alzheimer's disease (AD),
demanding novel precision medicine approaches to inform prescribing guidelines and risk-benefit assessment.
Critically, this emerging class of AD therapeutics carries significant risks, including amyloid-related imaging
abnormalities (ARIA) associated with brain edema and microhemorrhages, and brain atrophy, for which the
mechanisms and long-term consequences remain undetermined. Risk for ARIA increases dose-dependently
with APOE4, the strongest single genetic risk factor for AD that is also associated with elevated blood-brain
barrier (BBB) permeability and cerebral amyloid angiopathy. Evidence implicating cerebrovascular fragility in
ARIA development, attributed to immunotherapy-triggered A clearance from blood vessels, suggests that
BBB dysfunction may be a critical mechanism underlying ARIA, and perhaps serve as a valuable biomarker for
predicting and monitoring ARIA. Consistent reports of brain atrophy following anti-A immunotherapies raise
concern for drug-induced acceleration of neurodegeneration, yet the cellular changes contributing to volume
loss on structural MRI have not been investigated. Distinguishing benign alterations in fluid dynamics or
inflammation from neuronal loss will be essential for ensuring safe and effective widespread roll-out of these
novel agents. The proposed investigation will address these pressing outstanding issues by integrating
advanced MRI techniques into real-world clinical settings to evaluate BBB permeability and brain
microstructure as biomarkers for ARIA risk and treatment response.
A-positive individuals prescribed anti-A immunotherapy will undergo cognitive assessment, amyloid PET,
and plasma AD biomarker measurement at screening and 12-months, as well as routine MRIs to screen for
ARIA. Participants will complete research MRIs, including restriction spectrum imaging to measure brain
microstructure and dynamic contrast-enhanced MRI to quantify BBB permeability, prior to treatment, upon
detection of ARIA, and at 12-months. This project will test the hypotheses that pre-treatment BBB permeability
and abnormal microstructure predict ARIA incidence and colocalize with regions of ARIA, and will characterize
trajectories of dynamics in BBB permeability and brain microstructure over the treatment course (Aim 1). BBB
leakage and microstructure are expected to predict and correlate with treatment response, as quantified by
change in cognition and AD biomarkers (Aim 2). Associations of BBB permeability and microstructure with
ARIA and treatment outcomes are expected to differ by factors previously suggested to modify anti-A
immunotherapy response, including sex, age, APOE4, and race/ethnicity (Aim 3). As the first study to directly
evaluate BBB breakdown and brain microstructure along the time-course of anti-A immunotherapy, this
project is anticipated to inform the development of critically-needed screening and monitoring biomarkers and
guide clinical recommendations that enhance safety, efficacy, and patient access.

Public health relevance
PROJECT NARRATIVE With the approval of anti-A immunotherapies for Alzheimer's disease, there is urgent need to understand the risk factors for ARIA and other adverse events, and the long-term effects of these novel agents on brain health. This project will be the first to integrate advanced MRI techniques into clinical practice to characterize the dynamics of blood-brain barrier permeability and brain microstructure along the time-course of anti-A immunotherapy. Results will support the missions of the NINDS and NIA to develop screening tools to optimize treatment safety and efficacy, by informing the mechanisms of ARIA and clarifying the elusive observations of drug-induced brain atrophy, while probing biomarker differences among sub-populations that have been under- represented in clinical trials.